Spatial and temporal organization of cellular functions at membrane contact sites

PROJECT SUMMARY
Membrane contact sites (MCSs) play critical roles in spatially organizing cells and facilitating the transfer of
biological materials between organelles. MCSs are defined as sites of close apposition between membranes
that are physically tethered by protein-protein or protein-lipid interactions and perform specific biological
functions. These sites of contact are a ubiquitous mechanism used by cells to facilitate communication between
organelles and are associated with a wide array of cellular functions. Given their importance in maintaining
cellular homeostasis, it is not surprising that MCSs have been implicated in a wide range of diseases, including
neurological diseases, cancer, and pathogen-induced diseases. Our plan for the next five years is to build on
the successes we have had studying mitochondrial MCSs and address fundamental unanswered questions that
are widely applicable to MCS biology. Our work will be primarily grounded in the yeast system. The simple
organelle architecture of budding yeast has proven to be an excellent model for studying MCS form, function,
and regulation in mechanistic detail. Our studies in yeast over the past five years have opened avenues of
scientific exploration that have broadened the scope of our research program beyond a limited view of a single
MCS. Our research program will follow three independent yet complementary directions, each of which will
address a critical unanswered question in MCS biology. We will continue our studies on a tripartite membrane
contact site between the mitochondria, endoplasmic reticulum, and plasma membrane to elucidate how and why
three distinct membranes are brought into functional close contact. We will explore the fundamental mechanisms
by which MCSs are coordinately regulated at two different length scales— within a shared space and across the
MCS network. We will also examine the role of lipids as critical structural, functional, and regulatory components
of MCSs. Our prior accomplishments and plans for the next five years will place us in a strong position to initiate
studies in mammalian systems, in which we will examine how the fundamental principles of MCS formation,
function, and regulation we uncover in yeast are utilized in more complex cellular settings. Our goal is to uncover
fundamental mechanisms used by cells to form and regulate interorganelle contacts and deepen our
understanding of MCS physiology. In doing so, we anticipate this work will provide insight into novel therapeutic
strategies for a range of human disease conditions in which the manipulation of MCSs can be used to positively
influence cellular health and homeostasis.

Public health relevance
PROJECT NARRATIVE Membrane contact sites (MCSs) are a ubiquitous mechanism used by cells to facilitate communication between organelles. Despite their prevalence, few MCSs have been characterized in detail at the molecular level, and, for those that have, their precise functions remain elusive. The goal of the proposed project is to elucidate the fundamental principles underlying the formation, function, and regulation of MCSs, providing insight into ways MCSs are harnessed to influence cellular homeostasis and how MCS dysfunction contributes to disease states.